Cancer Research Training Program in Tanzania (CRTP-TZ)

PROJECT SUMMARY
East Africa faces unprecedented growth in cancer burden and is inadequately prepared to meet this population
health crisis. In the context of limited resources, it is imperative that policies are evidence-based and target
cancers with highest incidence, morbidity, and mortality rates in the local region. As cancer prevention and
control programs in Tanzania and East Africa continue to develop, trained human resources for research and
cancer care will be critical to sustain and expand these efforts. As a regional training hub, Muhimbili University of
Health and Allied Sciences (MUHAS) is uniquely positioned to play a major role in building capacity for cancer
research in Tanzania and the East Africa region at large. Building upon a shared commitment to improving health
outcomes through education and mentoring, MUHAS and the University of California, San Francisco (UCSF)
propose to strengthen and expand the existing Cancer Research Training Program in Tanzania (CRTP-TZ). Our
overarching goal is to train and mentor a multi-disciplinary cadre of investigators in East Africa who are capable
of conceptualizing, achieving funding for, implementing, analyzing and publishing original research focused on
cancer. Our hypothesis is that East African investigators will create and lead an impactful and thriving hub of
cancer research if proper attention is given to selection, provision of high-quality foundational didactic training,
mentorship, curation of a conducive environment, and professional development. The immediate objectives of
this renewal application for the CRTP-TZ are: (1) to expand our cadre of research Scholars originating from
Tanzania and other countries in East Africa who are diverse in discipline and who are likely to build successful
academic research careers related to cancer control science; (2) to provide rigorous, interdisciplinary training in
cancer research methods; and (3) to provide each Scholar with sustained mentorship and professional
development opportunities that foster both scientific and career advancement. We propose a training model
which leverages existing resources in Tanzania and supplements with rigorous, high-quality coursework and
sustained mentorship from UCSF. Specifically, we propose a training program with three unique pathways, which
avail flexibility to build upon pre-existing competencies and the need to align training opportunities with individual
career goals. We will provide sustained mentorship and a professional development curriculum for Scholars in
each of the three training pathways. In summary, we intend to train a multi-disciplinary cadre of cancer
researchers within East Africa who will enhance cancer control through performance of high-quality research and
development of sustainable and comprehensive African-led research programs.

Public health relevance
PROJECT NARRATIVE East Africa is one of the fastest growing regions of the world, with an increasing burden of non-communicable diseases, including cancer. Cancer research in the region is nascent; however, the rising cancer burden urgently demands development of research skills and capacity to establish context-specific cancer control plans. The overarching goal of the Cancer Research Training Program in Tanzania (CRTP-TZ) is to train and mentor a multi-disciplinary cadre of investigators from East Africa who are capable of conceptualizing, achieving funding for, implementing, analyzing, and publishing original research focused on cancer control.